Mechanisms of slits3 signaling in thermogenic adipose tissue

Project Summary
The regulation of body temperature, thermoregulation, is a fundamental homeostatic process in warm-blooded
organisms. Brown adipose tissue (BAT) plays an important role in the control of body temperature by generating
heat in cold environments. BAT is functionally distinct from white adipose tissue (WAT) which is the primary site
of energy storage. Once activated by cold, BAT dissipates the chemical energy as heat in a process called
adaptive thermogenesis. Activating and expanding the thermogenic adipose tissue are attractive ways to
increase energy expenditure and offer promising strategies to combat obesity and cardiometabolic diseases.
Notably, studies in humans and rodents show that the biological significance of thermogenic adipose tissue
extends far beyond enhancing energy expenditure. Due to their high metabolic activity, thermogenic adipocytes
act as a metabolic sink to improve glucose and lipid metabolism and thus exhibit anti-diabetic and lipid-lowering
effects. The major challenge in targeting BAT as an anti-obesity therapy is the limited amount of active BAT in
most adult humans. Although using chronic cold exposure as a preventive or treatment strategy is not feasible,
understanding the mechanisms of cold adaptation presents a unique opportunity to exploit these pathways and
develop strategies to increase BAT thermogenesis and improve systemic metabolism. Using single-cell
transcriptomic analysis of BAT and analyzing the cell-type-specific transcriptional changes in BAT from mice
housed at different temperatures, we have recently revealed that thermogenic adaptation involves the multi-
layered and coordinated remodeling of all adipose resident cells to enhance thermogenesis. Through extensive
analysis of ligand-receptor communications, we have constructed the intricate network of intercellular crosstalk
within the thermogenic adipose niche. Within this framework, we identified the axon guidance ligand Slit3 as an
essential regulator of BAT thermogenesis. Our functional studies demonstrated the role of Slit3 in the regulation
of angiogenesis and sympathetic innervation, firmly establishing Slit3 as a key player in the control of BAT
thermogenesis. However, the mechanisms by which Slit3 signaling influences these processes remain unknown.
Building on our recent discovery and exciting preliminary data, we propose a series of innovative strategies to
determine the contribution of Slit3 proteolytic processing to its function in BAT (Aim 1), identify the molecular
mechanisms of Slit3 signaling in endothelial cells and sympathetic neurons (Aim 2), and address the potential of
Slit3 to ameliorate the detrimental effects of diet-induced obesity by promoting angiogenesis and preserving the
sympathetic innervation in BAT and WAT (Aim 3). Successful completion of the proposed studies will provide a
mechanistic understanding of an entirely new pathway that regulates adipose tissue function and will have an
important and sustained impact on the field.

Public health relevance
Project Narrative The development of strategies to prevent or treat obesity is among the top priorities for healthcare and research communities. Adipose thermogenesis plays a crucial role in enhancing whole-body energy expenditure and improving systemic metabolism. The proposed work aims to elucidate the mechanisms responsible for controlling the activation and expansion of thermogenic adipose tissue.